Core B - Resource for Pre-Clinical Studies of AKI

Project Summary
Small animal models of human disease have provided important insights into renal pathophysiological
processes and are an important preclinical resource to test therapeutic and preventive approaches in acute
kidney injury (AKI). The specific aims of Core B are to provide the facilities and requisite skills 1) to study
murine models of AKI, 2) for small animal imaging, and 3) to determine renal pathophysiological changes in
AKI. This core will specifically provide (i) expertise in development and training in the use of rodent models of
AKI specifically in the setting of ischemia/reperfusion injury, sepsis and kidney transplantation, (ii) a multi-
modality small animal imaging core that will provide state-of-the-art molecular imaging, including functional,
structural and metabolic imaging using magnetic resonance imaging/spectroscopy, high frequency
ultrasonography, microCT, gamma-ray imaging (gamma camera, microSPECT/CT, microPET/CT), and optical
imaging (bioluminescence and fluorescence), and (iii) a physiology core that will provide expertise and training
for studying renal function on the whole kidney and at the single nephron level, including micropuncture
techniques and determination of GFR, microanalysis of tubular fluid and tubular reabsorption, renal
hemodynamics with assessment of tubuloglomerular feedback, and metabolic assessment of kidney oxygen
consumption in rodents. Core B will also provide technical expertise for the isolation of primary tubular and
vascular cells from rodents.
The intent of Core B is to provide unique resources that help overcome barriers for investigators to utilize
relevant rodent models for in vivo studies and rodent kidney cells and cell lines for in vitro studies to advance
understanding of the pathophysiology of AKI. Core B has been very successful in supporting the kidney
research community. Since the inception of the O'Brien Center, Core B has performed more than 12,000
procedures for 200 investigators. A steady number of investigators use Core B each year. In the present
funding cycle, of the 120 investigators, 91 (76%) were non-core investigators. Core B has also supported the
research efforts of 20 Pilot and Feasibility and Catalyst grant awardees. These combined efforts have been
currently recognized in 105 peer-reviewed publications. The sophisticated infrastructure coupled with the
unique expertise of Core B will continue to catalyze collaborative activities of our investigator base and
advances in AKI research.